Leadership and Administrative Core

PROJECT SUMMARY LAC
The purpose of the Leadership and Administrative Core (LAC) is to provide the administrative infrastructure
and scientific leadership necessary to achieve the overall aims of the UConn OAIC. The long-range goal of the
LAC is to lead the way in establishing a highly productive research and education program at the University of
Connecticut (UConn), spanning laboratory, clinical and community, and population-based science guided by
the theme of Precision Gerontology. This goal will be addressed through 4 specific aims: (1) Provide OAIC
leadership to ensure successful administration and integration of all OAIC activities. The LAC will coordinate
activities of all administrative entities within the UConn OAIC, including the Steering Committee, the External
Advisory Board, the Independent Review Panel and the Community Advisory Board. During monthly Steering
Committee meetings, the LAC will monitor progress of all Cores and Components, and lead discussions about
how to continuously develop collaborative research and education activities across Cores and Components.
The LAC also will ensure timely submission of progress reports to the External Advisory Board and NIA; (2)
Explore and assess opportunities for scientific progress aligned with emphasis on multidisciplinary team
initiatives consistent with the UConn OAIC theme of Precision Gerontology and the OAIC mission. During
monthly Steering Committee meetings, the LAC will facilitate ongoing discussion about how to promote
development of UConn’s research portfolio consistent with the Precision Gerontology theme. The Steering
Committee is a highly multidisciplinary group and represents the continuum of research from bench to bedside
to population, ensuring a fertile environment for exploring and assessing opportunities for scientific progress;
(3) Ensure full compliance with all regulatory requirements. The LAC will ensure that all studies supported by
UConn OAIC funds meet all UConn and federal human subjects and animal protection compliance regulations
before they are permitted to commence, and will monitor ongoing compliance of OAIC-supported studies with
relevant regulations until they are completed; (4) Evaluate progress of OAIC Cores and Components to
achieve UConn OAIC research and educational goals. The LAC will help design evaluation tools for all Cores
and Components, compile evaluation results, and use evaluation results to continuously improve the UConn
OAIC’s capacity to achieve its research and educational goals. By accomplishing these Aims, the LAC will
provide the scientific leadership and administrative oversight necessary to promote and grow multidisciplinary
geriatric and gerontological research at UConn related to the UConn OAIC theme of Precision Gerontology.
The accumulation of knowledge through research related to Precision Gerontology will help contribute to
improvement and restoration of independence of older adults.